Methylation in binge ethanol-induced spleen atrophy in adolescent rats

Project Summary:
This revised U01 research project is in response to PAR-16-214 with the Funding Opportunity Title, “Program
for Extramural/Intramural Alcohol Research Collaborations”. Sulie L. Chang, Ph.D. and Ming D. Li, Ph.D. will
be the two extramural investigators at Seton Hall University, and David Goldman, M.D. will be the intramural
investigator at NIAAA/NIH. For their alcohol research collaborations, they will share their unique, yet
complementary, expertise and experiences as well as their research facilities and other resources.
The project goal is to delineate the involvement of DNA methylation in binge ethanol (EtOH)-induced
spleen atrophy during adolescence. Adolescence is an important period for maturation of various
physiological functions, including immune responses. Binge alcohol drinking, defined as consumption of
excessive amounts of alcohol in a short time resulting in a blood EtOH concentration (BEC) of at least 0.08
g/dl, is popular among adolescents and can lead to addictive behaviors and eventually alcoholism in
adulthood.
Atrophy of the spleen, a key immune organ, is highly associated with immune dysfunction. We have
shown that treatment with 4.8 g/kg/d EtOH for 3 d differentially decreases the size of the spleen in 5 wk old
adolescent male F344 rats, but not in adult rats. There was also a decrease in the area of the splenic white
pulp and a distortion of white pulp structure in Sprague Dawley rats binge treated with EtOH. Expression of
CD3, a T cell marker, was decreased. The CD3+ T cell population was also differentially decreased in F344
rats given binge EtOH. These data showed that loss of T cells might partially, account for distortions of white
pulp and the overall relative spleen weight. The expression of caspase-3, a key enzyme for cell death,
negatively correlated with the relative spleen weight, indicating that binge EtOH induces loss of T cells
leading to distortions of the white pulp and spleen atrophy, in part, due to apoptosis.
DNA methylation is an epigenetic event that operates through post-transcriptional modification of DNA by
DNA methyltransferases (DNMTs) to regulate gene expressions. One of our preliminary studies showed that
treatment with 5-Aza-2′-deoxycytidine (5-AZ), an inhibitor of DNA methylation, reversed binge EtOH-induced
spleen atrophy. In parallel, we also found that significant decreases of DNMT1 expression in the spleens of
rats given binge EtOH. The qRT-PCR array data showed that 6 genes were significantly downregulated
among 84 immunity and EtOH metabolism related genes after binge drinking. Taken together, we
hypothesize that DNA methylation is involved in binge EtOH-induced regulation of various target genes
leading to apoptosis of T cells, distortion of white pulp, and spleen atrophy during adolescence. To test
this hypothesis, in this revised application, we propose the following three aims: Aim 1 is to investigate the
effects of binge EtOH consumption on spleen atrophy, and to isolate and characterize CD3+ cells for the
studies in Aims 2 and 3. Aim 2 is to investigate the role of methylation in binge EtOH-induced spleen atrophy
using genome bisulfite sequencing (WGBS), followed by genome-wide methylation analysis (GWMA). Aim 3 is
to determine the involvement of methylation in binge EtOH-induced spleen atrophy at the gene expression and
mechanistic levels by studying the expression of methylated genes, including the known EtOH regulated genes
(KERGs) and WGBS identified methylated genes (WGIMGs). In addition, the methylation inhibitor, 5-AZ, will
be used to confirm if methylation of these identified genes (e.g.,methylated KERGs and WGIMGs) is involved
in binge-EtOH induced expression of these genes.
The proposed studies have combined data-driven discovery and hypothesis-driven investigation together.
We expect to identify whole-genome methylated loci in the spleens of adolescent rats subjected to a binge
EtOH regimen and the methylation loci of the KERGs and WGIMGs and determine the expression and
activities of the proteins encoded by these genes. With these information, we will be able to develop
epigenetic-based interventions to curtail binge alcohol-induced spleen injury during adolescence.

Public health relevance
Project Narrative: This project will investigate the involvement of DNA methylation in binge ethanol (EtOH)-induced spleen atrophy during adolescence. Addition of the methyl (-CH3) groups to DNA from the spleens of rats given binge exposure to EtOH for 3 days will be investigated to identify the methylation loci that might be mechanisms underlying EtOH’s effects on the adolescent spleens. Our study will provide valuable information which could lead to the development of new strategies for the treatment of alcohol abuse by adolescents.